Career Enhancement Program

Project Summary – REDIAL Career Enhancement Program (CEP)
Translational research related to population disparities in pediatric acute lymphoblastic leukemia (ALL) is lacking,
with a shortage of investigators investing their career in this area. The Career Enhancement Program (CEP) is
designed to provide incentives, training and guidance to attract academic physician-scientists, clinicianinvestigators, and laboratory-based scientists to dedicate their efforts to this area of research. A key goal of the
CEP is to support early faculty in order to nurture a robust future translational research environment. Another
goal is to support established investigators who may wish to refocus their careers on research in this area.
To meet these goals, the specific aims of the CEP are to recruit, train, and guide a new group of physicians and
scientists to become successful translational investigators focusing on population-based disparities in outcomes
in pediatric ALL; to educate awardees in the basic principles of ALL biology, epidemiology, therapy and
toxicities, clinical outcomes, and the multifactorial bases for population-based disparities in outcomes; and
to develop and collect metrics to assess the success of the CEP, allowing the program to be reviewed and
modified as necessary. To achieve these aims, we have developed specific criteria for selection and funding
through a peer- reviewed mechanism, and we will collaborate with the Baylor College of Medicine Office of
Community Outreach and Engagement in the selection of candidates for the CEP program. We will ensure that
program awardees are integrated into the SPORE so their progress can be monitored and opportunities for
obtaining external funding enhanced. The SPORE will also take advantage of best practices and evaluation tools
identified in other centers and entities at BCM that have pilot project funding. Strong mentorship is an important
component of the CEP, through which awardees will be instructed in the principles of clinical, basic, and
translational research relating to ALL outcome disparities. Population-based mentors will provide role models to
CEP awardees. Specific areas of education include scientific and clinical methods, biomedical ethics, statistical
design and analysis, genetics and genomics, pharmacology, epidemiology, and other areas relevant to individual
projects. Mentorship will include laboratory-based investigators, clinical investigators, biostatisticians and
epidemiologists. Mentors from within the U54 SPORE as well as other faculty members at BCM and the other
SPORE sites will provide the expertise required to develop strong, productive translational research skills.